Structure, function and regulation of the H2B ubiquitin-conjugating complex

PROJECT SUMMARY: Protein ubiquitination functions in many biological processes. Histone ubiquitination,
an epigenetic mark, governs DNA-related processes though chromatin structure and transactions.
Misregulation in ubiquitination and epigenetic mechanisms are linked to numerous inherited and acquired
diseases including diabetes, cancers and neurological disorders. Histone H2B monoubiquitination (H2Bub1)
regulates gene transcription from yeast to humans. This proposal focuses on the evolutionarily conserved
budding yeast H2B ubiquitin-conjugating complex (HUC) comprised of Rad6 (E2 conjugase), a homodimer of
Bre1 (E3 ligase) and Lge1 (an accessory protein). Assembly, recruitment, and regulation of HUC complex are
not fully understood. Using extensive functional, biochemical and structural studies including a preliminary
crystal structure for Rad6-Bre1 sub-complex, we have identified multiple subunit interfaces that are distinct to
the HUC complex compared to other ubiquitin-conjugating complexes including a novel interface between a
non-catalytic region of Rad6 and a non-RING domain region of Bre1, an asymmetric conformational state of
the Bre1 dimer, and Lge1 binding near the Bre1 RING domain. We will use X-ray crystallography to visualize
these distinctive subunit contacts in Aim 1. Lge1, an essential but uncharacterized accessory protein, binds
chromatin factors and Bre1 and is expendable for Rad6-Bre1's K63-linked polyubiquitination activity, prompting
the intriguing hypotheses that Lge1 recruits the HUC complex to relevant sites on chromatin and restricts its
activity to monoubiquitination, which will also be tested in Aim 1 using genomics to determine the genome-wide
occupancy of the HUC complex and a biochemistry-proteomics combination to measure mono versus poly
ubiquitination. Aim 2 builds on our confirmation of in vivo phosphorylation of serine-120 near Rad6's catalytic
cleft. Our preliminary structure for Rad6 with the phosphomimetic aspartate substitution suggests that S120
phosphorylation is a molecular switch that `closes' down the active site to inhibit monoubiquitination but allow
polyubiquitination. This will be tested by determining the structure of S120-phosphorylated Rad6. Our
preliminary data also involves the discovery that the cell wall integrity pathway kinase Mpk1 phosphorylates
Rad6. This motivates the model that this modification activates Rad6 to polyubiquitinate substrates during
transcription initiation and in upstream signaling events, and that subsequent dephosphorylation makes Rad6 a
H2B monoubiquitinase during transcription elongation promoting gene expression. This innovative regulatory
switch theory will be tested in Aim 2 using a multipronged approach to determine genome-wide occupancies,
transciptomes and ubiquitomes regulated by Rad6 and Rad6S120phos. In summary, our multidisciplinary
studies will advance the ubiquitination and epigenetics fields by addressing fundamentally important functional
and mechanistic questions regarding Rad6 and the HUC complex. Given the evolutionary conservation, our
studies are applicable to the epigenetic and ubiquitination mechanisms in metazoans including humans.

Public health relevance
PROJECT NARRATIVE We aim to advance the understanding of the histone H2B ubiquitin-conjugating complex by using a wide range of approaches that are revealing molecular structures, mechanisms of molecular recognition, and novel signaling pathway functions. These studies are providing new insights to the fields of epigenetics and cellular regulation by revealing mechanisms that regulate protein ubiquitination. This is of fundamental importance for numerous cellular processes, and underlies the pathogenesis of many diseases including diabetes, stroke, sclerosis, cancers, and neurological disorders.